Be Well at Work-Plus: Engaging low-wage workers in the design and implementation of a depression and physical activity intervention - Administrative Supplement

Be Well at Work-Plus: Engaging low-wage workers in the design and implementation of a
depression and physical activity intervention (PI: McCurley)
Brief Summary
Depression and physical inactivity are leading contributors to cardiometabolic diseases such as
obesity, diabetes, and cardiovascular disease. Low-wage workers, who comprise one-third of all
workers in the U.S. and are essential to many industries, are more likely to be physically
inactive and to have cardiometabolic conditions and depression, yet they are half as likely as
higher wage workers to utilize preventive care. Targeted workplace initiatives have been
successful in improving employee health, but low-wage workers are difficult to engage, in part
due to a high burden of social disadvantage (e.g., food and housing insecurity, time and
financial constraints). This K23 study is adapting an evidence-based 8-session telephone-
delivered depression intervention for working adults, Be Well at Work, and adding critical
enhancements for low-wage workers: assessment and referrals for social determinants of health
(e.g., food and housing insecurity, financial stress), physical activity promotion, and
personalized text message behavioral support. The adapted intervention, Be Well at Work-
PLUS, will be tested in two phases: (1) a single-arm pilot (N=10) with exit interviews to refine
the intervention content and delivery (Aim 2); (3) a pilot randomized controlled trial comparing
Be Well at Work-PLUS to a waitlist condition (N=60; Aim 3). This iterative process will yield
results on feasibility, acceptability, and preliminary clinical outcomes of Be Well at Work-PLUS
and provide data to apply for an R01 efficacy trial. This Life Event that pertains to this
supplement application is the birth of my second child in 2024 and my resulting parental leave.
In addition to my 12-week parental leave, I experienced reductions in productivity in 2024 due to
(1) adjustment to caring for two young children (I also have a 4-year-old); (2) frequent absences
from work due to child illnesses contracted in child care; and (3) time dedicated to breastfeeding
and pumping to feed my infant. This supplemental funding will provide critical, time-sensitive
staff support to ensure that my K23 study is completed during the planned timeline. The
supplement will fund effort for a postdoctoral fellow (a clinical psychologist) to help deliver the
study intervention and additional effort from a research coordinator to complete study
coordination tasks. This support will allow me to dedicate more time to manuscript and grant
writing so that I meet my goal of submitting R-level awards using pilot data from this study.

Public health relevance
Be Well at Work-Plus: Engaging low-wage workers in the design and implementation of a depression and physical activity intervention (PI: McCurley) Project Narrative Low-wage workers comprise one third of all workers in the U.S. and have a high prevalence of cardiometabolic risk factors, including depression and physical inactivity. The proposed project develops and tests a dynamic workplace-based depression intervention that is tailored to the specific social and behavioral needs of low-wage workers and enhanced with text message support for mood and physical activity. The proposed Life Events Supplement will provide timely staff support from a Postdoctoral Fellow and Research Coordinator to ensure that study aims are completed as planned despite the PI's child birth and maternity leave in 2024.